The National Health and Aging Trends Study and National Study of Caregiving

Project Summary
The purpose of this application is to extend and enhance the National Health and Aging Trends Study (NHATS)
and the National Study of Caregiving (NSOC) to promote the study of late-life disability, Alzheimer's Disease
and Related Dementias (ADRD), and related care. The overarching aims of NHATS and NSOC are to promote
scientific inquiry into late-life disability and ADRD trends and dynamics, their antecedents and correlates, and
disparities therein, providing the research community with timely, rich, annual data on physical, cognitive, and
sensory functioning and family care. Additionally, NHATS and NSOC provide rich data on the consequences of
late-life disability and ADRD for individuals, families, and society. To achieve these aims in the next five-year
cycle, we will continue the unique key design features of NHATS including annual in person data collection from
a nationally representative sample of older adults (Medicare enrollees) in 2024-2028 (Rounds 14-18) and mixed
mode (web/phone) follow-up with family caregivers participating in NSOC. We will also implement several
innovative scientific enhancements and enrichments of key domains of the disablement process in the NHATS
conceptual framework, including: (1) enriched historical and contemporaneous linkages to residential location,
enhancing access to measures of life course exposures to factors that shape late-life racial and ethnic health
disparities; (2) an expanded accelerometry study to better assess movement, sedentary behavior and sleep
patterns as they related to the disablement process and ADRD; and (3) expanded measures in cognitive and
sensory functioning, residential care settings, and end-of-life care. Extending and enhancing NHATS and NSOC
in these ways will allow important scientific questions to be addressed concerning both shorter and longer-term
in-depth trends and dynamics in disability, ADRD, and related care and will guide efforts to maximize functioning
and enhance quality of life of older adults and the families who care for them.

Public health relevance
Project Narrative The National Health and Aging Trends Study and National Study of Caregiving promote scientific inquiry into late-life disability and Alzheimer's Disease and Related Dementias (ADRD) trends and dynamics, their antecedents and correlates, and disparities therein. The studies are a platform for researchers to engage in scientific inquiry to guide efforts to improve health, functioning, and care for older adults.